Mechanisms of alteration of gastrointestinal physiology by gut microbes

PROJECT SUMMARY/ABSTRACT
Irritable bowel syndrome (IBS) is a globally prevalent disorder (~11%) characterized by an alteration
in stool form/frequency in association with abdominal discomfort or pain. IBS is categorized into
constipation, diarrhea or mixed (IBS-C, IBD-D, IBS-M) based on the predominant stool form/frequency. The
pathophysiology of IBS is complex and therapeutic options targeting the underlying pathophysiology in IBS
are limited. Recent studies support a role for gut microbial metabolites in maintaining normal
gastrointestinal (GI) function, but how changes in different microbial metabolites and interactions among
these metabolites affect molecular pathways involved in IBS pathophysiology remains a critical knowledge
gap. Hence, it is not surprising that the current empirically designed microbial therapies (probiotics) have
largely proven ineffective in IBS. To address this gap, in the previous grant cycle we focused on the
bacterial metabolite tryptamine and found tryptamine increases secretion and mucus release in a 5-
HT4R dependent manner, accelerates transit, and protects against inflammation in rodent models. The
observations were supported by our finding of elevated levels of tryptamine in IBS-D in our human study. In
the same longitudinal multi-omics human study, the most consistent finding in IBS-C across multiple -omics
platforms were significant decreases in stool hypoxanthine and butyrate. The overall objective of this
proposal is to determine the physiologic relevance of these metabolites by identifying the molecular
pathways affected by each of these metabolites that are relevant to IBS-C. Our central hypothesis based
on prior research and our preliminary data is that hypoxanthine is an effector metabolite that
accelerates GI transit by increasing enterochromaffin (EC) cell serotonin release while butyrate is a regulatory
metabolite that augments the biologic activity of effector metabolites. This will be tested in two Aims: In Aim
1, we will determine the mechanism by which hypoxanthine increases EC cell serotonin release and
accelerates GI transit and in Aim 2, we will determine the mechanism by which butyrate regulates EC cell
responses to effector metabolites and the resultant effects on GI function. We will use Ca2+ imaging in
organoids/primary EC cell culture from novel transgenic mice, heterologous receptor expression with site-
directed mutagenesis, and epigenomic and transcriptomics data, combined with ex vivo colon
preparations, gnotobiotic- and EC cell-depleted mouse models, isogenic bacterial mutants, and novel
encapsulation methods to address the above aims. Our findings will uncover specific pathways by which
these microbial metabolites affect GI transit and allow development of novel mechanism-based microbial
therapies for IBS-C.

Public health relevance
PROJECT NARRATIVE Irritable bowel syndrome (IBS) affects nearly 11% of the population worldwide, significantly impacts patients’ quality of life and imposes a huge economic burden due to loss of productivity and high healthcare costs. Gut bacteria play an important role in IBS, but the mechanism remains unclear; thus, we do not have effective probiotics to treat IBS. This proposal will uncover how specific bacterial products affect gastrointestinal motility and allow development of more effective probiotic therapies for IBS.